New biomaterials for ocular surface reconstruction.

DESCRIPTION (provided by applicant): The ocular surface is vulnerable to myriad insults including mechanical, chemical and thermal injuries. The resulting trauma may render the naturally occurring regenerative properties of the cornea incapable of restoring a healthy epithelial surface with a resultant loss of corneal transparency and vision. Bioengineered scaffolds derived from silk have been used to restore function to damaged tissues in number of organ systems. Although some progress has been made in ocular surface reconstruction, the emphasis has been on mechanisms to cultivate cells, while less focus has been placed on identifying means to alter the substrate on which the ocular surface epithelium is destined to grow. The proposal has 2 aims: 1) To determine the optimal nanoscale surface features promoting corneal epithelial cell adhesion and migration, and 2) To optimize cell adhesion and migration on silk films using peptide surface modifications. The above exploratory Aims will examine our hypothesis that nanoscale features and surface modifications are critical for the adhesion, proliferation and migration of corneal epithelial cells vivo. The Aims will lay the groundwork for future experiments combining modifications of ocular surface epithelial cell substrates using thin silk films as conduits for potential bioengineered ocular surface reconstruction. PUBLIC HEALTH RELEVANCE: The ocular surface is vulnerable to myriad insults including mechanical, chemical and thermal injuries. The resulting trauma may render the naturally occurring regenerative properties of the cornea incapable of restoring a healthy epithelial surface with a resultant loss of corneal transparency and vision. We propose to design bioengineered tissues composed of with surface properties that will facilitate repair of the eye.

Public health relevance
PROJECT NARRATIVE The ocular surface is vulnerable to myriad insults including mechanical, chemical and thermal injuries. The resulting trauma may render the naturally occurring regenerative properties of the cornea incapable of restoring a healthy epithelial surface with a resultant loss of corneal transparency and vision. We prose to design bioengineered tissues composed of with surface properties that will facilitate repair of the eye.